UCSF-UCB TRAC ADMININSTRATIVE CORE

PROJECT SUMMARY – Administrative Core
The UCSF-UCB TRAC Administrative Core will provide leadership, infrastructure, administrative support,
coordination, and oversight for all services across both Scientific Cores, Basic and Clinical, and the UCSF-UCB
TRAC Developmental Core. The UCSF-UCB TRAC Administrative Core will bind together the functions and
resources of all the Cores, including assuring linkages to relevant programs at the two campuses. The
Administrative Core will provide the governance and financial management structure, and the monitoring and
evaluation required for smooth operation of this multi-core Center, with the ultimate aim of facilitating exciting
new directions in multidisciplinary TB research in conjunction with mentorship and career development across
the UCSF-UCB TRAC Cores. The Administrative Core will coordinate communication between the UCSF-UCB
TRAC components and between the UCSF-UCB TRAC and NIAID Program staff. The Administrative Core will
manage, coordinate and oversee all the UCSF-UCB TRAC activities, monitor progress and ensure that the
program milestones are being met and implemented effectively within the proposed timelines. The Administrative
Core will establish and run a Core Management Committee (CMC), chaired by the UCSF-UCB TRAC co-
Directors, that oversees and advises all UCSF-UCB TRAC Cores and program activities. The CMC will be the
central decision-making body of the TRAC and will be composed of the Center co-Directors, Cores co-Directors,
TB researchers not directing Cores, and community engagement representation. The Administrative Core will
establish and support a UCSF-UCB TRAC Community Advisory Board (TB CAB), an Internal Advisory
Committee (IAC) and an External Advisory Committee (EAC) as part of the TRAC management plan. Through
this oversight, the Core will ensure multi-directional communication and collaboration between all UCSF-UCB
TRAC members and our target audience of TRAC resource users, including new investigators and established
investigators new to the field of TB research.